NRSA Training Core

The TL1 program at the New York University (NYU) – Health and Hospitals (H+H) CTSI provides innovative, university-wide, transdisciplinary training of the next generation of scientists conducting clinical and translational research (CTR). Our trainees arrive at an advanced stage of training, with established areas of inquiry and capable primary research mentors, but require further mentoring and experience. Our guiding premise is to change their worldview from one of personal scientific success, to a broader and more creative mindset where they interact continually and span disciplinary boundaries to advance knowledge and health. Our program is unique in both the wide scope of disciplines represented and in being the only T-supported program at our hub to include trainees from clinical, basic, and non-STEM backgrounds. Trainees work across the lifespan and with various populations to develop new approaches to improve health, and collaborate to develop transdisciplinary and team-building skills and a broader translational vision. To support the emergence of clinical and translational scientists, our TL1 program provides full-time pre- and post-doctoral research training focusing on trainees interested in careers in CTR. Our three specific aims are to: 1) develop trainees with the collaborative skills needed to lead multidisciplinary CTR teams; 2) enhance trainees’ communicative effectiveness across the CTR spectrum; and 3) accelerate trainee career progression into independent CTR positions. Beyond supporting each trainee’s methodologic skills and discipline-specific advancement, we focus on trainee development to provide the skills most often cited as underdeveloped in multi-disciplinary, team-based science. To extend beyond research training in specific disciplines, we promote the “Three Cs”—Collaboration, Communication, and Career Development. The foundational project that transforms this aspirational philosophy into actual behavioral change is our every-other-week Student-to-Scholar (STS) seminar—a forum where trainees meet, reflect, learn, bond, and teach one another. Each session addresses an aspect of the three Cs. Trainees conduct their own discipline-specific research with their research mentor and take additional courses related to the three Cs (e.g., manuscript writing, team science, responsible conduct of research, career planning, grant writing), and one elective course (e.g., health policy, drug development). Trainees also participate in the annual Association of Clinical and Translational Science meeting, our CTSI’s fortnightly Translational Research in Progress (TRIP) seminar, our monthly TREC Grand Rounds in Career Development, and an annual T and K research symposium/networking meeting, hosted by NYU and including all CTSAs in the NYC area. We emphasize faculty recognition of and response to the unique needs of each trainee, while maintaining a cohort model to provide support, encouragement, and accountability. In the next funding period, our augmented mentor-training program will emphasize co-mentoring so each trainee gets optimal personalized development as a translational scientist.